Fracture Fixation Biomechanics Simulator with Adaptive Virtual Coaching

Project Summary
Obtaining proper biomechanical stability to promote healing is a primary goal of fracture fixation surgical
procedures. Subpar fracture fixation can result in fracture nonunion, residual deformity, implant failure, disuse
atrophy, osteopenia, and short or long-term disability. Patients present with variable fracture geometries, bone
quality, activity level. Surgeons have many choices for implant types, sizes, materials, construct configurations,
and postoperative weightbearing strategies. All these factors, as well as the patient’s innate fracture healing
capacity, affect postoperative biomechanics and resulting clinical outcome. Community orthopaedic surgeons
who are not trauma specialists often need to treat these fractures. Although surgical technique has received
much attention in the medical simulation literature, there is increased recognition of the importance of simulation
in the cognitive and decision-making aspects of surgery. The proposed project develops and tests a new
interactive simulation software that enables a surgeon to make changes to patient variables and fracture fixation
plan, and immediately visualize how these changes affect clinically important 3D biomechanics. The technology
is enabled by our high-throughput simulation approaches for generation of precomputed results libraries. The
project relies on close long-term collaborations between academic biomedical engineers and clinician scientists,
enhanced by collaboration with a leading open-source visualization software research and development
organization. The project tests the hypothesis that interactive visualization of 3D biomechanics in fracture
fixation will improve biomechanical knowledge and fracture fixation plans. Specific Aim 1 develops and tests
effectiveness of a refined simulation software, combined with an instructor-led session, for education of 3D
fracture fixation biomechanics. The rich interface will include validated parametric simulations of three
fundamental fracture fixation types (bridge plating, compression plating, and intramedullary nailing) applied to
both simplified bones and to proximal femur fractures. Specific Aim 2 introduces an autonomous, adaptive virtual
coach integrated into the software. The virtual coach will enable flexible, personalized training for each surgeon
based on their progress. The project will provide new, exciting opportunities for providing deeper biomechanical
understanding to the surgeons who create fracture fixation constructs, facilitating precision medicine and
promoting safer and more effective surgical procedures.

Public health relevance
Project Narrative Surgical care of fractures is an important part of modern orthopaedics, but subpar surgical decisions can result in fracture nonunion, residual deformity, implant failure, or long term disability. Patients present with highly variable fracture patterns and bone quality, and selecting an appropriate implant type, size, material, screw configuration, and postoperative weightbearing plan can be challenging for surgeons. This project develops and tests an innovative simulation software interface, with a virtual coach, that enables interactive visualization of 3D biomechanics involved in fracture fixation.